Core 2: Genomics

ABSTRACT
The Genomics Core (Core 2) will provide support with genomics profiling and integrative bioinformatics
analysis support for all the four projects, contributing towards the Program's overall goal to understand the
regulatory mechanisms of the BRCA network in DNA damage repair and replication fidelity, and the
maintenance of genomic integrity to suppress tumorigenesis. The Genomics Core will be led by Dr. Subhajyoti
De, PhD, who is an internationally known genomics scientist with >10 years experience working in the area of
cancer genomics and DNA repair. His lab is a state-of-the-art fully equipped genomic facility staffed with expert
personnel specializing in genomics and bioinformatics analysis including whole genome sequencing, RNA-
Seq, ChIP-Seq, ATAC-Seq, and chromatin conformation sequencing approaches. Dr. De has extensively
collaborated with the principal investigators on this P01 project, as evident from shared grantsmanship and
publications. Dr. Chang Chan, PhD, co-investigator on this core is also the co-leader of the Genomics
Instability and Cancer Genomics program at the Rutgers Cancer Institute jointly with Dr. Shen, and has
extensive collaborations with the P01 investigators. Dr. Yaqun Wang, PhD, the other co-investigator has close
collaborations with the P01 investigators. The Core has generated preliminary data from the mouse tumors,
identified genomic alterations, and performed initial data analysis. The specific aims of the Genomics Core
(Core 2) are: 1) identify architecture of complex genomic rearrangements using genomics approaches, (ii)
annotate complex chromosomal rearrangements in cancer genomes, and (iii) perform integrative
bioinformatics analysis of BRCA network. Two innovative aspects of the Genomics Core are (i) usage of
emerging genomic technologies to determine patterns of complex rearrangements in cancer genomes, and (ii)
use both sequence and epigenomic contexts of the structural rearrangements to annotate them and predict
underlying etiologies. Core 2 will be central to the preparation of all Program presentations, reports, and
manuscripts that seek to understand the regulatory mechanisms of the BRCA network in replication fidelity and
DNA damage repair.

Public health relevance
NARRATIVE The Genomics Core will assist all four projects, by performing genomics and bioinformatics analyses for this program project. Genomic data generated by this Core will be used to advance our understanding of the role of BRCA network in genome maintenance and cancer.